Development of therapeutics for SCA48

Abstract
C-terminus of HSC70 Interacting Protein (CHIP) is a neuroprotective protein that is beneficial in many different
neurodegenerative diseases. More recently mutations in CHIP have been identified as the cause of two
neurodegenerative diseases. Recessive mutations in CHIP cause Spinocerebellar ataxia autosomal recessive
type 16 (SCAR16), while dominant mutations cause Spinocerebellar ataxia type 48 (SCA48). While SCAR16 is
a very rare disease, SCA48 is a more common form of ataxia. Many mutations that cause SCA48 exist in the
tetratricopeptide repeat domain of CHIP and map to a single interface between the first and second TPR repeat
of CHIP. That led us to investigate the importance of this domain. Our findings indicate that mutations in this
domain cause SCA48 by inducing a structural change that partially unfolds the TPR domain of CHIP. Importantly
this unfolding event can be reversed by addition of excess ligand suggesting that mutations that cause SCA48
do not terminally unfold the TPR domain of CHIP. Importantly these results also suggest that one could identify
small molecules that stabilize this domain and thus may be therapeutic for patients with SCA48. Here we propose
to optimize and miniaturize a series of assays. These assays will then be utilized to screen for small molecules
that restore the proper fold and function to the TPR domain of CHIP. Compounds from the screen will then be
evaluated with secondary and tertiary assays to identify hits. These hits will then be tested in cell culture models
of SCA48 to see if they reverse disease phenotypes. Together the work proposed in this application will put us
on the road to developing small molecules that may one day be therapeutically useful.

Public health relevance
Project Narrative The E3 ubiquitin-ligase C-terminus of HSC70 Interacting Protein (CHIP) has neuroprotective properties. Recent findings in patients have identified mutations in CHIP as the cause of Spinocerebellar ataxia type 48 (SCA48). The goal of this proposal is identify small molecules that may be used to treat SCA48.